Training & Dissemination

Training and Dissemination Project Summary
The broad mission of our Center for Advanced Imaging Innovation and Research (CAI2R) is to bring
together collaborative translational research teams for the development of high-impact biomedical imaging
technologies, with the ultimate goal of changing day-to-day clinical practice. The Training activities of CAI2R
are addressed at educating trainees and collaborators (1) in the best use of our technologies, and also (2) in
the formation and operation of successful translational research teams. Our Dissemination team, meanwhile, in
addition to sharing numerous individual software and hardware tools for imaging, will aim for a broader impact
by providing (1) large imaging datasets for developing machine learning methods, and (2) comprehensive tools
for the integration of new imaging technology into clinical workflows.